LOW RESOLUTION DATA COLLECTION OF YEAST RNA POLYMERASE II (POL II)

We have recently obtained high resolution three dimensional crystals of Pol II at atomic resolution diffraction. We are now pursuing modified crystals, including a tight binding inhibitor and cocomplexes with DNA and DNA/RNA ternary complexes as simple routes to heavy atom derivatives. We have improved our crystals from an earlier limit of 30 E for unfrozen crystals to better than 3.5 E on our recent run using flash freezing and are attempting to improve the purity of the protein for lower mosaicity. Simultaneously, we are attempting to obtain the lowest resolution reflections for a direct phasing of the protein.